Strengthening California's Food Testing Surveillance Program

Micro A: Track 2 Project Abstract/Summary Application Title: Enhancement of California's Integrated Food Safety and Security System Project title: Strengthening California's Food Testing Surveillance Program The California Department of Health, Food and Drug Laboratory Branch (FDLB) is the State food testing laboratory which serves as the primary servicing laboratory for the State of California’s manufactured food regulatory program (MFRP) for microbiological and chemical analyses. FDLB is enrolled through the Food and Drug Branch in the food safety inspection contract with the Food and Drug Administration (FDA) and the MFRP. The purpose of this analytical track is to improve food testing surveillance programs through the microbiological analysis of food products and environmental samples. The test results generated by FDLB can be used to remove adulterated food from commerce and aide regulatory inspection programs in conducting investigations.

Public health relevance
Micro A: Track 2 Project Narrative Application Title: Enhancement of California's Integrated Food Safety and Security System Project title: Strengthening California's Food Testing Surveillance Program Strengthening of California's Food Testing Surveillance Program ensures the technical competency and capability of the laboratory to perform Food Surveillance testing for a variety of manufactured food products. It helps to expand the network of laboratories that have the capacity support food surveillance testing. This ensures that FDA and its state partners are able to respond swiftly and rapidly to adulterated food products to prevent a foodborne outbreak. Specific tests and the results generated from the laboratory for food surveillance testing can be used by the Food and Drug Administration (FDA) to remove adulterated food products from the consumers. Increased activity through this cooperative agreement would increase analytical capacity for the FDA and advance a nationally integrated food safety system, which enhances food safety. These practices support the new and innovative program initiated by the Food Safety Modernization Act (FMSA).